Core 2: Recruitment and Retention Shared Resource Core

The primary objective of the AMPLIFI Recruitment and Retention (RR) Shared Resource Core (SRC) is to
support the AMPLIFI Projects and the Adaptation, Dissemination and Implementation (ADI) SRC by providing
recruitment and retention services. The successful recruitment and retention of study participants to research
projects is critical to scientific discovery, and often a significant challenge in survivorship research. This SRC
builds on exceptional collective work of the RR SRC leaders and other AMPLIFI investigators who successfully
recruited cancer survivors to research studies for the past two decades. The SRC leverages an impressive
facility at the University of Alabama at Birmingham: the Recruitment and Retention Shared Facility (RRSF) of
the UAB Comprehensive Cancer Center is a nationally recognized minority recruitment site that has served in
several large national efforts including the Prostate, Lung, Colorectal and Ovarian (PLCO) Cancer Screening
Trial and the Cancer Care Outcomes Research and Surveillance Consortium (CanCORS). The RR SRC
specific aims are to: (1) Recruit participants to AMPLIFI projects and ADI SRCs. The recruitment goal is
852 survivors with obesity/physical activity related cancers that have >70% 5-year survival (i.e., stage I multiple
myeloma, localized kidney cancer and loco-regional cancers of the colorectum, female breast, prostate,
endometrium, and ovary); who are from 1-5 years from diagnosis; who have completed primary cancer
treatment; and who have no metastasis or recurrence. The RR SRC will use population-based ascertainment
methods to recruit survivors from four state cancer registries (AL, MS, NC, TN) with a significant representation
of older, rural and underserved minorities. The RR SRC will also recruit the 48 stakeholders for ADI SRC
activities. Recruitment materials and a website will be developed to enhance survivors' awareness and
knowledge of research. Moreover, while a navigation approach has been used to recruit to primarily cancer
therapeutic trials, the RR SRC will use it in a novel way to recruit survivors in this behavioral research to
overcome personal barriers to participation. The RR SRC will monitor recruitment yield overall and separately
for older, rural and underserved minority survivors, and address recruitment challenges on an on-going basis;
(2) Retain participants in AMPLIFI. A purposeful plan for retaining participants will target drop-out prevention
at the primary (retention starting at recruitment by carefully screening potential participant), secondary (early
identification of survivors who may drop-out) and tertiary (recovering participants who drop-out) level in
Researcher, Participant and Contextual domains. As in the approach to recruitment, retention will include
simple, proven measures enriched by the principles of enhancing research awareness and knowledge, and a
navigation approach. In summary, the RR SRC team, together with other AMPLIFI investigators and the
professional staff of the RRSF, is uniquely and exceptionally positioned to achieve the proposed aims,
expedite the achievement of AMPLIFI goals, and contribute to the advancement of survivorship research.

Public health relevance
RECRUITMENT AND RETENTION SHARED RESOURCE CORE PROJECT NARRATIVE The AMPLIFI Recruitment and Retention (RR) Shared Resource Core (SRC) will recruit and retain cancer survivors for the proposed Projects and for the activities of the Adaptation, Dissemination and Implementation (ADI) SRC. Survivors will be recruited from four states in the southeastern US. By achieving its aims, the RR SRC will significantly contribute to the advancement of survivorship research and, ultimately, to the well-being of millions of cancer survivors including those who may be traditionally underserved such as older, rural, and minority survivors.